Validation of an aqueous humor liquid biopsy for molecular prognostication and monitoring of children with retinoblastoma.

Project Summary
There is a significant body of research into the genetic, genomic and epigenomic alterations of retinoblastoma
(RB), a primary eye cancer that forms in the developing retina in young children. However, these studies were
done on tumor tissues from surgically removed (enucleated) eyes with advanced RB, as tumor biopsy is not
possible due to the real risk of tumor extraocular dissemination. As a result, RB tumor DNA was never previously
accessible aside from these enucleated specimens, and there is limited understanding of the molecular
alterations that may drive tumor behavior. Furthermore, any application of molecular diagnostic or use of
prognostic biomarkers for personalized medicine in vivo is limited by the lack of tumor tissue at diagnosis or
during therapy. Thus, a liquid biopsy approach, which overcomes this critical lack of tumor tissue, was needed
for this disease. With support of an NCI K08, we demonstrated that the aqueous humor (AH), an intraocular fluid,
is an enriched source of tumor-derived cell-free DNA (cfDNA). We developed a liquid biopsy assay to detect
somatic copy number alterations (SCNAs) and pathogenic variants in the RB1 tumor suppressor gene from a
single 100 l sample of AH. We identified that the genomic alterations from the AH are highly concordant (>94%)
with those found in the tumor of enucleated eyes. We identified potential candidate biomarkers, chromosome 6p
gain and/or focal MYCNa in the AH cfDNA that are associated with a 16.5-fold increased risk of treatment failure
requiring surgical removal of the eye. We demonstrated that changes in AH cfDNA tumor fraction (TFx) correlate
with treatment response, with increases in TFx indicative of recurrence or minimal residual intraocular disease.
This suggests that TFx alone may serve as a reliable real-time biomarker for treatment response. We also
demonstrated the feasibility of evaluating tumor methylation profiles using the AH, thereby facilitating a better
understanding of tumor biomarkers that may predict tumor behavior and potentially treatment response. Based
in these results, we hypothesize that AH cfDNA can be used for molecular characterization of in vivo RB tumors
to inform diagnosis and prognosis for eye salvage based on validated genomic and epigenomic biomarkers. To
test this hypothesis, we now propose a multi-center, multi-omics, prospective study to characterize prognostic
AH biomarkers prospectively and longitudinally to determine treatment outcomes.
Benefits from this study will include advancing knowledge about the course of the disease at any stage, providing
biomarkers to guide treatment, and forming the basis for future molecular-based, precision medicine clinical trials
for RB.

Public health relevance
Project Narrative Retinoblastoma is an eye cancer that forms in the developing retina of young children; it is unique in that it cannot be directly biopsied, making tumor tissue unavailable. As a result, there is a lack of understanding of the association between the clinical behavior of this cancer and the mechanisms that drive its behavior. Thus, we propose to use a liquid biopsy of the eye aqueous humor for molecular characterization and prognostic biomarker validation of this cancer to help the design of future clinical trials.